Administrative Core, Center for American Indian and Rural Health Excellence (CAIRHE)

Title: Administrative Core, Center for American Indian and Rural Health Excellence (CAIRHE)

Modified Project Summary/Abstract Section

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.

The overarching aim of the Center for American Indian and Rural Health Excellence, or CAIRHE, is to position itself as the state and regional leader in multidisciplinary health research and to increase the number of Center investigators achieving independent status. The PD/PI and support staff of the Administrative Core will execute the Organization and Management Plan to provide administrative and fiscal leadership of the research center at Montana State University, drawing on counsel from the Advisory Committee (AC) and Internal Mentor Council. On a wider scale, the Core will provide leadership statewide and across the region in American Indian and rural health through collaborative research and educational partnerships. Internal evaluation will focus on key benchmark questions and indicators related to the Pilot Projects Program and its faculty mentoring; the career development of faculty investigators under the Career Guidance Plan; and progress toward viability of the Montana IDeA Community Engagement Core (CEC) and the Translational Biomarkers Core. The Center will continue its successful Pilot Projects Program to increase the number and capacity of health researchers at MSU. With oversight by the PD/PI, in addition to the AC and the Internal Mentor Council, the Career Guidance Plan involves both individual and team mentoring of these early-career investigators. The Core also will provide fiscal management for the project leaders and external grant development services necessary for their career development and their transition to, and attainment of, independent researcher status. The Administrative Core will work closely with the CEC to develop and maintain collaboration with partners belonging to the Center’s innovative Health Excellence Network. One particular focus of COBRE Phase III will be to leverage the Health Excellence Network for the dissemination and implementation of successful partnership-driven research outcomes among communities in need across the state and region. Finally, the Core will enhance the Center’s Viability Plan to guide CAIRHE in the transition from COBRE funding to other competitive grant support during COBRE Phase III and beyond. Upon achieving its Aims by the completion of Phase III, the Administrative Core will have further established a highly visible and effective collaborative, multidisciplinary center—with viable cores—focused on health research. Through the successful execution of CAIRHE’s Career Guidance Plan and Viability Plan, a growing number of independent investigators within the Center will position CAIRHE for success beyond COBRE Phase III as an institutionalized center that is a permanent contributor to the biomedical research capacity at Montana State University.